The role of neutrophils in the age-driven decline in anti-pneumococcal vaccine responses

ABSTRACT
Despite the availability of vaccines, Streptococcus pneumoniae (pneumococcus) infections in the elderly
remain a health and economic burden in the USA. This calls for a better understanding of pathways driving
immune dysregulation in aged hosts, reducing vaccine efficacy and rendering this population susceptible to
infections. Our long-term goal is to elucidate the role of polymorphonuclear leukocytes (PMN) in the age-
driven reduction in vaccine responses and increased susceptibility to S. pneumoniae infection. Background:
A key immune cell following S. pneumoniae infection is PMN. PMNs are innate cells required for controlling
bacterial numbers and whose function is known to decline with age. Recent work shows that PMNs are
important regulators of adaptive immunity. However, the role of PMNs in clinically relevant vaccinations and
their impact in the reduced vaccine efficacy seen in aging remains completely unexplored. We found that
vaccination with the pneumococcal conjugate vaccine Prevnar-13, failed to protect old mice against
pneumococcal infection. Further, in young hosts, optimal protection following vaccination required PMNs both
at the time vaccine administration and at the time of pneumococcal-challenge, highlighting the role of PMNs as
both inducers and effectors of vaccine responses. This led to the Hypothesis that age-driven changes in
PMNs result in the decline of vaccine efficacy against S. pneumoniae in the elderly. Here we test this
hypothesis in both murine models and human volunteers with the following Aims: 1) Test the role of PMNs as
effectors in the decline of pneumococcal vaccine efficacy during aging. 2) Test the role of PMNs as inducers of
the age-driven decline in pneumococcal vaccine efficacy. 3) Test the effect of host aging on PMN responses
following vaccination in human donors. Significance/ innovation: Elucidating the role of PMNs in the decline
in vaccine efficacy against pneumococci in the elderly will vastly contribute to our understanding of how aging
alters innate immune responses and how innate immunity in turn regulates the decline in adaptive memory
responses. Further, understanding the role of PMNs, which are involved in host defense against multiple
pathogens, is imperative for future design of better preventative approaches against pneumococci and other
relevant infections that target the vulnerable elderly population. This proposal is perfectly in line with NIA’s
mission to promote healthy aging.

Public health relevance
Project Narrative: This proposal is designed to uncover the role of neutrophils in the age-driven decline in vaccine efficacy against Streptococcus pneumoniae, the leading cause of community-acquired bacterial pneumonia in the elderly. This will allow identification of novel targets to boost memory responses in the elderly.